The Role of Intermediate Filaments in Inflammation

Abstract: Intermediate filaments are highly conserved eukaryotic cytoskeletal proteins present in
nearly every cell in the body. Although initially thought to simply provide structural support to cells,
intermediate filaments are now implicated in a variety of biological processes due to their
numerous protein interactions. Due to the number of intermediate filament monomers, more than
70 in humans, and the complexity of their regulation, more than 100 posttranslational modification
sites, gaps remain in our understanding of the molecular mechanisms by which they are regulated
and by which they contribute to many biological processes. To begin to fill these gaps, we seek
to define molecular mechanisms by which intermediate filaments are regulated in cells and to
define how intermediate filaments contribute to inflammation by focusing on their role in neutrophil
inflammatory processes and migration. This proposal builds on the PIs previous experience
investigating intermediate filament function during bacterial infection by proposing to leverage
new cellular models of immortalized neutrophil populations with established screening
approaches successfully use by the PI to define molecular mechanisms by which the intermediate
filament vimentin contributes to inflammatory processes. The flexibility in funding provided by this
R35 program will enable the PI the flexibility to follow the most promising lines of investigation
and to leverage the proposed approaches to train junior scientists within the laboratory. The
successful completion of the proposed studies is highly likely to improve our general
understanding about the biological processes in cells to which intermediate filaments contribute
and to our understanding of the mechanisms by which neutrophil function is regulated during
inflammation.

Public health relevance
Narrative: Intermediate filaments are abundant cytoskeletal proteins that interact with numerous cellular proteins and contribute to a variety of cellular processes, yet we lack a complete mechanistic understanding of their function. Here we propose to interrogate how intermediate filaments are regulated and how they contribute to inflammation by focusing on the intermediate filament vimentin and its role in neutrophil inflammatory processes and trafficking. The successful completion of this proposal is highly likely to identify new mechanisms by which intermediate filaments contribute to inflammation and to cellular and tissue function.